Adolescent Health Training Program

This is the first submission of this application for competitive renewal of the fourth cycle of the Adolescent Health
Promotion Research Training Program at the Johns Hopkins School of Medicine. The goal of the program is to
provide training in sexual and reproductive health (SRH) research to post-doctoral Adolescent Medicine
physicians. While there has been some major success in utilizing effective interventions to address the high
rates of SRH morbidity among adolescents and young adults (AYA), significant age- and racial-ethnic health
disparities exist for youth in the United States. This is compounded by workforce shortages of individuals who
are trained in Adolescent Health with specialized skills to use scientific evidence to ensure the healthy transition
of youth into adulthood. Adolescent Medicine specialists, physicians who have contact with AYA in clinical
settings, must also serve as leaders in the development and implementation of new prevention strategies to
effectively prevent STIs, HIV, and unplanned pregnancy. This requires physicians to critically understand the
biopsychosocial development of adolescents and to build upon scientific advancements derived through
collaboration with nurses, psychologists, epidemiologists, behavioral, social, and basic scientists, and
statisticians. We have created an interactive, interdisciplinary, team-science training environment using an adult
learning model that facilitates effective engagement of physicians and research scientists across pertinent
disciplines to foster the development of our trainees. Over the last decade, we have successfully recruited and
retained a diverse pool of fellows, most of whom are women and half are from under-represented minority
groups. Of the fellows appointed to the grant in the last cycle, 100% completed advanced graduate coursework
at the Bloomberg School of Public Health and 80% entered the program with or formally obtained advanced
degrees, all fellow graduates who attempted subspecialty certification boards have been successful, all
graduates were employed in a related field at fellowship completion, and two recently received NIH K23 mentored
awards. Based on these successes, we now request an additional five years of funding to continue to support
three fellows per year. The Adolescent Health Promotion Training program at Johns Hopkins University is
uniquely qualified to develop and maintain such a program given the active research programs in our unit, the
quality of our core faculty, the successful outcomes of our previous trainees, the infrastructure, resources, and
environment available to foster research development, and the continuous influx of bright dedicated physicians
committed to careers in Adolescent Medicine. Our program also emphasizes innovation at the intersection of
SRH and the social ecology of adolescence to reduce health disparities in line with national health objectives.

Public health relevance
The Adolescent Health Promotion Research Training Program provides training in sexual and reproductive health research to post-doctoral physicians training in Adolescent Medicine. This program is designed to address national health and workforce disparities in adolescent health and responds to the Healthy People 2030 objectives. Physician graduates will ultimately contribute to the scientific development of innovative and effective prevention strategies for pregnancy and sexually transmitted infections, including the human immunodeficiency virus, among youth.